Coordinating Center

NATIONAL COORDINATING CENTER - ABSTRACT
The Children's Environmental Health Network (CEHN), through partnership with Emory's CHARTER center,
proposes to serve as the CEHRT National Coordinating Center (NCC). CEHN is a national organization with
nearly 30 years of experience leading the field of children's environmental health across sectors. Its
commitment to supporting, synthesizing, and sharing rigorous independent science, its long history of
convening diverse audiences, and the trust that it has earned among communities and stakeholders, positions
CEHN well to act as the national CEHRT hub for collecting, sharing, and exchanging CEH knowledge. CEHN
will work collaboratively with NIEHS, the funded CEHRT Centers, and Sharecare, Inc. (a leading US digital
health company) to advance the overall goals of the CEHRT Program and leverage the collective science into
meaningful action for the public. A steering committee will be formed to guide the functions of the NCC and to
assure that the Core is outward facing and inclusive of external CEH stakeholders. An advanced digital hub will
be established to integrate and optimally disseminate the work of each of the funded Centers, NIEHS, CEHN,
and Sharecare. Sharecare's ability to quickly produce diverse media will help to ensure that the work of each
Center is optimally represented within the hub; the company's dissemination channels (email, social, app, etc.),
combined with the dissemination channels of CEHN, NIEHS, and the CEHRT Centers, will ensure that
messages are dynamically and strategically shared with national audiences. Once the web infrastructure is
formed, the NCC will leverage the hub's assets and interconnectivity to coordinate and streamline initiatives
across the CEHRT network. In addition, CEHN will provide: efficient coordination of CEHRT Network activities
and meetings; a needed face fielding public inquiries about the program and directing people to appropriate
resources; and visibility to diverse stakeholders via targeted presentations. CEHN will partner with Sharecare
to integrate children's environmental health content from the CEHRT Network and beyond into their digital
platform for broad reach into their market. CEHN will collect the following: 1) Metrics on CEH engagement, 2)
Data on health actions/outcomes that can be traced to CEHRT messaging, and 3) Interpersonal insights about
the effectiveness of community implementation efforts. These insights will be applied to continuously refine
NCC strategies and precisely market initiatives.